Incentive Payments and Practice Patterns in Dialysis: The Case of Calcimimetics

Project Summary / Abstract
Up to 80% of patients with end-stage kidney disease (ESKD) receiving dialysis have secondary
hyperparathyroidism (SHPT), a condition of abnormal bone and mineral metabolism which is associated with
higher mortality, cardiovascular events, fractures, and parathyroidectomy. Calcimimetics, a mainstay of
treatment for SHPT, act by lowering parathyroid hormone (PTH) secretion; cinacalcet and etelcalcetide are the
two FDA-approved calcimimetics available in the United States. Before 2018, over 20% of Medicare
beneficiaries lacked access to these medications because they lack Medicare Part D (prescription drug
coverage). In 2018, all dialysis patients suddenly gained access through a change in Medicare policy known as
the Transitional Drug Add-On Payment Adjustment (TDAPA). Using administrative claims data from the United
States Renal Data System (USRDS), which houses Medicare claims for all individuals on dialysis, this project
will leverage the TDAPA policy as a natural experiment to evaluate its effect on calcimimetic prescriptions and
subsequent patient morbidity and mortality.
Aim 1 seeks to compare the prescribing patterns of calcimimetics for individuals on dialysis before and
during TDAPA, using a longitudinal differences-in-differences analysis to estimate the effect of the TDAPA
policy in patients without Medicare Part D coverage. Early studies of TDAPA suggest that calcimimetic
prescription patterns varied widely from facility to facility. Sub-Aim 1a will study differences between cinacalcet
and etelcalcetide use after implementation of TDAPA, focusing on comparing the facility characteristics
associated with greater likelihood of etelcalcetide use.
Aim 2 attempts to evaluate SHPT-associated outcomes and determine whether expanded access to
calcimimetics ameliorated poor outcomes through a differences-in-differences analysis of TDAPA. Though
SHPT is associated with morbidity and mortality, whether calcimimetics can improve such outcomes is less
clear, owing to limitations of randomized-controlled trials. In this aim, the TDAPA policy will be used as a
natural experiment to examine the causal, real-world effect of calcimimetics on SHPT-associated outcomes,
with broader implications for examining how Medicare policies affect important outcomes for patients on
dialysis.
The proposed work will serve as a post-doctoral fellowship training vehicle for the applicant at Stanford
University, under an interdisciplinary mentorship team bridging Stanford’s Division of Nephrology and
Department of Health Policy, with collaboration from the University of Southern California. This team brings
expertise in bone mineral disease, USRDS data, and econometrics that will equip the trainee with the
necessary skills to advance her career in health services research with a focus on the ESKD population.

Public health relevance
Project Narrative Many patients with kidney failure on dialysis experience abnormal bone metabolism, placing them at higher risk for death, cardiovascular events, and fractures, and may necessitate removal of the parathyroid glands. This condition is treated with a class of medications called calcimimetics, which before 2018, over 20% of dialysis patients could not access because of how they were paid for through Medicare. This project will evaluate a) whether a Medicare policy change enhanced access to these expensive medications and b) whether this translated to improvements in important patient outcomes, with broader implications for understanding how health policies have the potential to influence disease burden in dialysis patients.